NUTRIENT UTILIZATION IN AGING MAN : EFFECTS OF FASTING AND FEEDING

Will explore the metabolism of five body constituents, leucine, alanine, glycerol, palmitate and glucose, and see how aging and brief starvation (48-60 hours) affect their metabolism.